Imaging of Joint Response to Physiological Stress with Age, Sex and in Osteoarthritis

PROJECT SUMMARY
Osteoarthritis (OA) is a leading cause of pain and disability worldwide and results in a reduced quality of life due
to pain from common tasks such as walking or climbing and descending stairs. A particular challenge of OA is
detection of disease at an early and reversible stage before irreversible structural damage has occurred.
However, current imaging methods are performed in a static fashion and have limited sensitivity to joint function
or the tissue response to loading. There is a major need to evaluate the joint response from everyday loading
tasks, and how this response is altered in OA. Further, as age is a key risk factor of osteoarthritis, which
predominantly affects older adults, the role of aging in tissue changes and response to loading stress is of
particular interest.
PET-MRI offers simultaneous evaluation of multiple early markers of OA in all joint tissues. In particular, [18F]NaF
uptake can quantitatively evaluate bone metabolism, including bone perfusion and deposition of [18F] ions into
the bone matrix. Further, we have observed that joint loading acutely alters the bone physiology affecting
[18F]NaF uptake. This suggests that [18F]NaF uptake may be sensitive to increases in the metabolic response of
bone where there is breakdown of the whole-joint unit that results in focal increases in bone loading.
This project aims to develop a novel imaging “stress test”, based on [18F]NaF PET-MRI, that is able to evaluate
at a single time point, both the function of the whole-joint unit after physiological joint loading and multiple early
markers of OA. Our Specific Aims are to (1) develop a rapid, quantitative, dose- and time-minimized [18F]NaF
PET-MRI protocol to
evaluate joint function from a stair ascent/descent exercise “stress” test
; (2) evaluate
[18F]NaF PET-MRI imaging to detect and characterize differences in joint function associated with age and
between sexes; and (3) evaluate tissue response to loading stresses measured with PET-MRI in early OA and
whether abnormal response is predictive of OA disease progression.
The innovation of this project is the development of novel PET and MRI methods to assess the whole-joint
response to loading and evaluation of early degenerative disease changes affecting joint function and future OA
progression. The significance of this work is an imaging method that is able to rapidly assess joint function in
response to physiological loads, and evaluation of how this joint response evolves with age and between genders,
as well as the role of altered joint physiology in OA. This may allow us to detect early joint dysfunction at a single
time point, to not only study OA pathophysiology, risk factors, and phenotypes, but also to develop targeted
interventions.

Public health relevance
NARRATIVE Osteoarthritis (OA) is a leading cause of pain, reduced joint function, and disability, that reduces productivity and quality of life at tremendous cost to society. Diagnostic imaging of OA is limited by methods that largely assess late-stage disease changes or require longitudinal scanning and are performed in a static fashion that has limited sensitivity to joint function in response to loading from everyday tasks such as walking or climbing stairs. This work aims to develop a novel imaging “stress test”, based on [18F]NaF PET-MRI, that is able to evaluate at a single time point, both the function of the whole-joint unit from physiological joint loading and multiple early markers of OA.